2023 Preclinical Form and Formulation for Drug Discovery Gordon Research Conference and Gordon Research Seminar

Abstract
Global health, rare diseases, and other unmet medical needs have unique challenges in formulation prediction,
materials characterization, and delivery of chemical, biological, and cellular medicines. The purpose of the 2023
Gordon Research Conference and Seminar (GRC/GRS) on Preclinical Form and Formulation for Drug Discovery
is to accelerate the translation of promising drug candidates into commercial medicines by: (1) disseminating the
latest scientific and technical advances relevant to materials characterization, formulation and delivery of
chemical, biological, and cellular medicines; (2) fostering a vibrant, inclusive, and diverse scientific network; (3)
educating and engaging the next generation of scientists. This GRC/GRS brings together expertise and
unpublished data on diverse therapeutics to highlight the form and formulation challenges and opportunities that
span these modalities and integrate cross-cutting techniques and approaches. These therapeutics include
bispecific and multi-functional small molecules, peptides, proteins, nucleic acids, and “living” microbial medicines
with broad applications ranging from infectious diseases to oncology. Formulation and characterization
technologies cover both novel experimental and in silico approaches, with the ultimate goal of discovering
general principles and tools that can be applied to many drugs to prevent failure and inefficiency. Dissemination
and discussion of new knowledge and technologies are necessary to enable broad use and further progress that
will translate more drugs efficiently into the clinic. Form and formulation can also enable solutions to critical global
health challenges, and this meeting will amplify the need for World Health Organization zone 4 stability and
distribution requirements, low cost, and easy to administer formulation and delivery systems. This conference
will share successes, continuing difficulties, and lessons learned from academic, industrial, government, and
non-profit scientists to meet the needs of patients across the world. Beyond molecular and professional diversity,
the program agenda and efforts to recruit participants reflect the commitment of the leadership team to an
inclusive meeting with diverse participants including scientists from groups underrepresented in pharmaceutics,
chemistry and engineering. An important component of this inclusivity is training the next generation of scientists
and the combination of the Gordon Research Conference, for scientists at all career stages, and the Gordon
Research Seminar, for graduate student and postdoctoral scientists, enables early career scientists from a broad
range of backgrounds to share their research and interact personally with leaders in the field to grow their
networks and nurture their career goals.

Public health relevance
Project Narrative The 2023 Preclinical Form and Formulation for Drug Discovery Gordon Conference and Gordon Research Seminar will present cutting-edge research that can ultimately result in shorter drug development timelines, reduced costs, and superior medicines that are safer and more effective for patients. The goal of the conference is to accelerate the translation of promising drug candidates into commercial medicines by sharing the latest scientific and technical advances in drug formulation development, by fostering an engaged, inclusive and diverse scientific network, and by educating and engaging the next generation of scientists.